Immunogenetic determinants of cancer risk

PROJECT SUMMARY
It has been shown that variation in cancer risk is influenced by mutations that may be inherited,
caused by environmental factors such as smoking and ultraviolet exposure, or resulting from
random DNA replication errors. Here we propose a novel factor in cancer risk, which is related to
the genetic diversity of the immune system across humans and its ability to detect and eliminate
early cancers. Immunosurveillance is the concept that the immune system acts as a surveillance
system to detect and destroy neoplastic cells before they progress to a detectable malignant
cancer. This process relies on T cells, which recognize tumor mutation-derived neoantigens
presented by the human leukocyte antigen (HLA) molecules on the cell surface, resulting in tumor-
killing. While HLA genes are among the most polymorphic genes in vertebrates, including
humans, and are associated with several infectious diseases and can also increase the risk for
autoimmunity, our preliminary analysis suggests HLA diversity influences cancer risk. The goal of
this proposed research is to study the contribution of immunogenetics on the efficiency of tumor
immune surveillance and its ultimate effect on cancer risk. Our preliminary analysis demonstrates
an association between HLA homozygosity and increased risk of cancer in lung cancer. Using
large prospective cohorts of individuals with deep genetic and phenotypic data, we will investigate
the relationship of HLA diversity and lung and melanoma cancer risk and the interaction of HLA
immunogenetics with environmental risk factors. A murine carcinogen induced lung cancer model
will offer validation of causality as well as mechanistic insights for therapeutic targets. The insights
gained from these studies will potentially improve predictive cancer risk models in germline
carriers and suggest strategies for immune-mediated cancer prevention.

Public health relevance
PROJECT NARRATIVE With the revolutionary discovery of immunotherapy as a highly effective treatment for cancer, the immune system, and specifically the interaction between CD8 T cells and HLA molecules, has emerged as an essential player in cancer treatment, but its role in early tumorigenesis is understudied. Germline HLA heterozygosity been shown to improve tumor immunogenicity and thus response to immunotherapy as well as lower susceptibility to viral infection, but its role in cancer risk is unknown. This proposed research will use large, diverse clinical and genomic datasets and an in vivo model of HLA-mediated immune surveillance to implicate germline HLA zygosity in cancer risk, potentially identifying an important biomarker for increased cancer screening, and provide insights into the mechanism of HLA-mediated immune surveillance of early tumors to guide treatment and prevention strategies.